New Strategies for Peptide Mimicry

ABSTRACT
Our research program is focused on the development of new broadly applicable tools for peptide mimicry.
Peptides are an important class of compounds that modulate a variety of biological responses, including
as hormones, neurotransmitters, and antimicrobials. Occupying the space in between conventional small
molecules and biologics, they can also be designed to inhibit large protein-protein interaction surfaces.
However, strategies are needed to convert them into more stable molecules while retaining the bioactivity
of the native peptides, ideally employing scaffolds that can adopt precise secondary structures while
being amenable to rapid derivatization for library synthesis and screening. Towards that goal, we develop
new methods for late-stage peptide functionalizations, and devise new strategies for the synthesis and
conformational control of acyclic, highly functionalized peptidomimetics. This includes (1) the study of
azapeptide folding and the development of new strategies for their chemoselective functionalization and
rigidification, and (2) the discovery and application of new conformationally-constrained N-substituted
glycine peptoid monomers. These novel methods are then applied to the synthesis of bioactive peptide
analogs.

Public health relevance
PROJECT NARRATIVE In this proposal, new methods to access libraries of peptide conformers are described. These methods will ultimately enable structure-activity relationships (SAR) studies of bioactive peptides, while increasing protease stability and rigidifying peptide secondary structures. Taken together, this should expedite the discovery of peptidomimetics with improved therapeutic potential.